Understanding role of circadian disruption in pathogenesis of MS

ABSTRACT
Disease progression in multiple sclerosis (MS) is conceivably driven by mechanisms that contribute to
remyelination failure, and identification of these mechanisms is critical for developing novel therapies. Current
therapies for MS patients are ineffective at treating secondary complications that significantly impact quality of
life, such as sleep and fatigue. The long-term goal of this work is to discover new strategies to facilitate
remyelination in MS patients. While circadian and/or sleep disruptions are common in MS patients, their roles in
affecting the process of remyelination in the context of MS are unknown. The overall objective of this study
therefore is to understand the mechanisms by which circadian rhythm disruption may alter remyelination and
disease progression in MS. The rationale for these studies stems from preliminary observations that circadian
rhythm disruption (CRD) correlates with neurological deficits and leads to remyelination failure in animal models.
Our preliminary data demonstrates that the key circadian regulator, Bmal1, is expressed by oligodendrocyte
lineage cells in mice and MS brains and is critical for remyelination. Based upon these observations, our central
hypothesis is that “Bmal1-mediated circadian disruption contributes to remyelination failure and progression of
disease course in MS”. This hypothesis will be tested by three specific aims. Specific Aim 1 will assess the
contribution of CRD gene polymorphisms in MS patients with sleep disturbances and MS brain tissues to
correlate magnetic resonance imaging and pathology of the MS brains with genetic polymorphisms in key
circadian genes. As human studies are not amenable to manipulation, we propose to test the correlative findings
from the human studies using animal models of sleep deprivation and demyelination/remyelination. Specific Aim
2 will address whether changes in circadian rhythm lead to remyelination defects in animal models. Specific Aim
3 will investigate the consequences of cell-specific loss and gain of Bmal1 on CRD-mediated remyelination
defects. This proposal is conceptually innovative because we investigate a previously-unexplored link between
circadian disruption and the process of remyelination and oligodendrocyte biology. The approach is technically
innovative because we propose to use MS patient samples with sleep disruption, MS autopsy tissues, and animal
models with oligodendrocyte- and oligodendrocyte progenitor cell-specific deletion and overexpression of the
key circadian gene, Bmal1. The future of MS therapeutics lies in the identification of additional therapeutic targets
and in developing more comprehensive combinatorial strategies. This work will make a significant impact on the
field of MS research because it will reveal the link between circadian disruption and myelin repair failure, and in
the future will guide the use of drugs directed towards resetting the circadian rhythm to improve clinical outcome
for MS patients.

Public health relevance
Project Narrative The identification of cellular and molecular mediators of repair following demyelination is critical to developing therapies and drugs to ameliorate the progressive disability in patients with multiple sclerosis (MS). The proposed research is relevant to public health because of the novel link between circadian disruption, a common problem associated with MS patients, and the process of failed repair in MS. The proposed research is relevant to the mission of the NINDS because it will develop fundamental knowledge that may help reduce the burden of disease and improve the quality of life for MS patients.